Modulating the resolution of angiogenesis and normalization of the vasculature for therapeutic benefit

Cardiovascular diseases are a leading cause of morbidity and mortality worldwide. Defective vascular repair or
insufficient vascularization after disrupted or blocked blood flow often lead to ischemic peripheral artery diseases
and other cardiovascular disorders. Treatment options generally aim to re-establish blood flow through affected
vascular beds. Angiogenesis, or the formation of new blood vessels from existing vasculature, is fundamental
for forming and maintaining the microvascular network and blood vessels that are required for metabolically
active tissue growth and repair. Therapeutic angiogenesis is being actively pursued as a treatment to induce,
augment and control angiogenic responses and to restore blood supply to ischemic tissues. Most angiogenic
therapies have focused on activation of angiogenesis, using stimuli that promote the growth of new blood vessels
employing growth factors (e.g. VEGF), stem or progenitor cells, gene delivery and/or extracellular vesicles.
Outcomes have been mixed and have had limited therapeutic success. This is largely due to our incomplete
understanding of basic mechanisms that regulate the resolution of angiogenesis. Where the angiogenic
vasculature does not achieve resolution, the neovasculature is inherently leaky, disorganized, and unresolving,
resulting in edema, impaired function, and morbidity. What is poorly understood at this time are the fundamental
processes that regulate resolution of angiogenesis, so that more efficacious and specific therapeutic approaches
can be devised. We discovered that the membrane-anchored serine protease, testisin, is a novel proteolytic
orchestrator of microvascular endothelial cell remodeling during resolution of angiogenesis. Strong preliminary
data show that that testisin promotes VE-cadherin inter-junctional adhesions, suppresses a G-protein coupled
protease activated receptor-2-dependent proangiogenic signaling pathway and directs the laying down of a
provisional fibrin matrix required for directed endothelial cell migration for reparative angiogenesis. These unique
activities are unexpected, and reveal a major gap in our understanding of modulators of angiogenic pathways
utilized by endothelial cells to repair and normalize vasculature. The proposed research plan will utilize a
combination of molecular biology, biochemistry and cell biology techniques, in concert with several in vivo mouse
models to address the following specific aims: 1) to define mechanisms by which testisin deficiency impairs
resolution of angiogenesis, and 2) to test the therapeutic efficacy of augmenting the testisin pathway to promote
resolution of angiogenesis. Augmentation of natural processes that facilitate the normalization of vasculature
has potential for treatment of diseases that are perpetuated by unresolving or insufficient angiogenesis, and for
enhancing effective delivery of cancer therapeutics.

Public health relevance
Angiogenesis, or the formation of new blood vessels from existing vasculature, is fundamental for forming and maintaining the blood vessels that are required for tissue growth and repair. The goal of this research is to understand a novel and poorly understood proteolytic mechanism that is critical for angiogenesis and re- establishment of microvascular endothelial barrier integrity. Outcomes from this research can lead to new treatments for diseases that are perpetuated by unresolving or insufficient angiogenesis, such as cardiovascular diseases, diabetic wound healing, and ischemia, and for normalization of tumor vasculature for more effective delivery of cancer therapeutics.